cGAS-STING Pathway Targeting Replicative Adenoviruses with CD46 Tropism and AFP Promoter Conditional Replication Restriction for the Treatment of Hepatocellular Carcinoma

ABSTRACT
In the United States, hepatocellular carcinoma (HCC) is the ninth leading cause of cancer mortality, with about
30,000 new liver cancer cases diagnosed annually. HCC disproportionately affects individuals from
racial/minority populations including Asian Americans, Latinos, Native Americans and African Americans.
CD46 (Cluster of differentiation 46) targeting oncolytic adenoviruses (OA) represents a promising novel
therapeutic platform, given their low seroprevalence and high expression of CD46 in HCC, and ease of
manipulation of OA genomes. The cGAS-STING pathway represents the major immune mechanism for
neutralization of DNA viruses, including OAs. I propose the development and pre-clinical evaluation of
recombinant oncolytic adenoviruses with increased potency in the setting of tumor selectivity in the treatment
of hepatocellular cancer. Increased potency of vectors will be achieved through targeting and inhibiting the
cGAS-STING pathway. This central tenet to the project is a very high reward in nature and if successful, has
the potential to have a profound impact not only in HCC research but also will have broad application
pertaining to novel therapies in other cancers where oncolytic vectors can be used. The proposed research
and career development plan enclosed in this application would provide additional training and mentorship to
enable me to progress toward becoming an independent investigator in the field of oncolytic virotherapy for
advanced liver cancer. It would also provide substantial preliminary research that will serve as the basis for an
R01 application to be submitted during the final year of the K01 award.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Hepatocellular carcinoma (HCC) is predicted to be one of the leading causes of cancer-related death in the United States by 2020. Current treatments in advanced HCC patients are sub-optimal and novel therapies are in dire need. This proposal seeks to address these limitations through the development and pre-clinical evaluations of a novel set of recombinant oncolytic viral vectors with increased potency for the treatment of intermediate and advanced HCC.